TARGETED siRNA DELIVERY AS AN ANTI-HIV MICROBICIDE

Targeted siRNA delivery as an anti-HIV microbicide PI: Derek M. Dykxhoorn Project Summary: Human immunodeficiency virus (HIV) is a highly lethal lentivirus which over a protracted course destroys the host's adaptive immune system leaving them vulnerable to numerous opportunistic infections. Unlike most viruses whose genome replicates independently of the host cell's genome, the HIV-1 genome integrates into and is replicated with the host genetic material. Therefore, even if therapeutic approaches can inhibit new virus production, the viral genome remains intact and competent. Therefore, strategies that can prevent the uptake and integration of the virus would be of tremendous clinical value. The vast majority of HIV infections occur as a consequence of viral transmission through mucosal surfaces, such as the vaginal mucosa. The delivery of siRNAs that specifically silence host factors required for early events in the HIV life cycle to lymphocytes in the vaginal mucosa could prove to be an effective means of protecting individuals from HIV infection and serve as a potential microbicide. One of the main challenges facing the clinical application of siRNAs as a genetic therapy is the ability to delivery siRNAs to the cytoplasm of the appropriate target cell types. We have recently developed a novel lipid nanoparticle that is coated with an antibody recognizing the integrin molecule LFA-1 which is broadly expressed on lymphocytes. These immuno-nanoparticles will be used to deliver siRNAs to lymphocytes present in the vaginal mucosa of humanized mouse models of HIV. Given the high level of sequence heterogeneity, the propensity of HIV-1 to mutate and the inability of anti-HIV siRNAs to target the incoming viral RNA genome and prevent integration, alternative therapeutic targets are required to prevent the transmission of HIV. Host factors that are necessary for early events in the HIV lifecycle but are dispensable for cellular functioning could prove to be an effective therapeutic alternative. Using a high-throughput RNA interference-based screening platform, we have identified a large number of potential therapeutic targets that could serve to inhibit HIV integration when silenced. However, these factors require extensive analysis and characterization to ensure their safety and efficacy. We will be combining the LFA-1-mediated cell-type specific vehicle to introduce siRNAs targeting therapeutically relevant host factors as a potential means to inhibit viral infection in humanized mouse models of HIV. These experiments will provide the preclinical groundwork necessary for the development of an effective RNAi-based anti-HIV microbicide.

Public health relevance
Project Narrative: Heterosexual transmission is the leading cause of new HIV infections in the world. A microbicide providing true intracellular immunity would make a significant contribution to controlling the spread of this deadly virus. __SpecificAimsTextDelimiter__ 2. Specific Aims Infections of the mucosal surfaces, such as the vaginal mucosa, constitute the predominant natural mode of HIV transmission1, 2. Sexual transmission occurs when either cell-free or cell- associated virus infects lymphocytes (macrophage, dendritic cells and activated T cells) present in the mucosal tissues. After this initial exposure, the virus is quickly disseminated throughout the body3. Although an HIV vaccine that induces sterilizing immunity would be the most advantageous method for controlling the spread of HIV, thus far this has been an elusive goal4, 5. In the absence of an effective vaccine, a microbicide that could be used vaginally or rectally to prevent sexual transmission would make a significant contribution to controlling the spread of HIV. However, recent attempts to develop an effective anti-HIV microbicide have been unsuccessful6. As a result, the search for novel microbicidial approaches remains a high priority. RNA interference (RNAi) is a highly conserved endogenous mechanism that uses small RNA species to guide the sequence-specific silencing of gene expression7-9. The discovery that RNAi functions in mammalian cells to regulate important cellular processes suggested that harnessing these endogenous gene silencing pathways can prove to be an effective method for the targeted silencing of gene expression10-12. By mimicking the structure of the small RNA molecules that serve as the effector molecules for RNAi, in particular, the 21-23-nt small interfering RNAs (siRNAs), it is possible to direct the silencing of any target gene of interest. Harnessing RNAi through the introduction of exogenous siRNAs has emerged as a powerful tool for gene function analysis and the identification of potential drug targets. In addition, these approaches have served as the basis for therapeutic gene silencing approaches against a variety of intractable diseases. siRNAs targeting virtually every HIV gene, including the HIV LTR, have been shown to effectively inhibit HIV replication in tissue culture cell lines, as well as in primary CD4 + T lymphocytes and macrophage cells13-19. Although RNA interference-based approaches that directly target HIV can effectively inhibit viral replication, these molecules are unable to degrade the incoming viral RNA genome which remains protected by the viral core20. Therefore, even if new progeny virion production can be inhibited, the viral genome remains intact and competent for replication. These results suggest that the direct targeting of HIV genes could serve as a potential therapy for the control of an existing HIV infection and complement existing antiretroviral approaches. However, this approach is not suitable for the prevention of HIV transmission. As intracellular pathogens, viruses must exploit multiple host cell factors for successful infection and replication21. The targeted silencing of host factors that are required for HIV replication but dispensable for proper cellular functioning, particularly those that are required for early events in the HIV-1 life cycle prior to integration, may prove to be an effective means to prevent infection. Since host proteins are inherently more genetically stable than viral targets, therapies directed at host factors may prove more difficult for the virus to circumvent. We recently completed an RNAi-based full genome screen to better understand the host dependencies of HIV and to identify novel therapeutic targets22. This screen led to the identification of over 230 novel host factors required for HIV-1 replication, many of which acted in early stages of the viral lifecycle. These results have encouraged us to characterize several of these factors in more depth to better understand how they interact with the HIV lifecycle and to determine if they would be suitable therapeutic targets for an siRNA-based anti-HIV microbicide. The development of siRNAs as a suitable and effective anti-HIV microbicide is a multistep process. This involves the identification and characterization of potential therapeutic targets, the development of effective siRNA delivery strategies, and the in vivo characterization of the efficacy and safety of the siRNA-mediated silencing reagents and the delivery reagents in an appropriate model system. To that end we have developed a phased research plan. In the initial phase (R21) we will be characterizing several of the HIV dependency factors (HDFs) to assess if they are suitable targets for an HIV-1 siRNA-based microbicide. This will involve the characterization of these factors in relevant tissue culture model systems, as well as' in primary CD4+ T lymphocytes and macrophage. In parallel with these studies, we will be testing the in vitro efficacy and safety of a novel cell-type specific siRNA delivery system. In the second phase of the program (R33 phase), we will take the results from the first phase (the therapeutic targets and the optimized delivery vehicle) and test them in a humanized mouse model of HIV-1 infection for their potential utility as a microbicide. Specific Aims (R21): 1. Characterization of HIV-dependency factors that inhibit early events in the HIV-1 infection (prior to HIV integration) to determine how they intersect with the viral life cycle and to identify potential anti-HIV therapeutic targets. 2. Evaluate the efficacy and safety of silencing HDFs in primary CD4+ T cells and macrophages using an LFA-1-targeted-nanoparticle delivery system. Specific Aims (R33): 3. Determine the efficacy and safety of LFA-1-mediated siRNA delivery following mucosal application of siRNA-nanoparticle delivery agent. 4. Test the efficacy of HIV-1 replication inhibition following the topical application of LFA-1-liposome- siRNA nanoparticles.